RESEARCH IN HUMAN COMMUNICATION AND ITS DISORDERS

No changes from originally awarded application.
PROJECT SUMMARY/ABSTRACT
This application requests support for three postdoctoral positions in a multidisciplinary research training program
in the area of human communication and its disorders at Boys Town National Research Hospital (BTNRH). The
training program at BTNRH, currently in its 39th year, has provided postdoctoral training to a substantial number
of highly qualified scientists who are presently working in the field of communication disorders. The purpose of
the program is to fulfill two basic training needs: 1) advanced research training for applicants who are recent
graduates of speech and hearing, communication sciences or language-related doctoral programs, and 2)
training for applicants with a received doctorate in a related field of science, technology, engineering or
mathematics who would benefit from additional research experience in a collaborative, research-intensive
environment. The training program consists primarily of direct participation by trainees in behavioral and clinical
translational research under the sponsorship of one or more experienced, independent scientists serving on the
program faculty. Research at BTNRH is conducted in a wide range of disciplines and laboratories from clinical
audiology to language development, with the focus on questions concerning the mechanisms underlying human
communication and its disorders. The unique advantages of the BTNRH research environment for the training
program include: 1) a faculty consisting of 16 behavioral, clinical and translational clinical scientists who serve
as mentors; 2) a critical mass of research trainees, funded by a variety of mechanisms, including T32, F32,
COBRE and R01 grants; 3) a clinical staff with access to a large and varied pediatric and adult patient population;
4) modern, well-equipped laboratories and diagnostic clinics; 5) a stimulating mix of areas of research across
individual research laboratories; 6) access to support from software and hardware developers within BTNRH’s
Technology Core; 7) access to support in human subject recruitment and standard clinical testing from BTNRHs’
Human Subjects Core and 8) conditions that foster collaborative, multi-disciplinary research.
Trainees are selected from PhD's, DSc's, and MD’s in areas relevant to ongoing research programs at BTNRH
on the basis of their research capabilities and the likelihood of their interacting productively with training faculty.
Particular attention is paid to identifying and inviting applications to the program from under- represented minority
candidates and candidates with a disability. Every effort is made to enhance diversity in the postdoctoral training
program and eventually in the group of scientists performing research related to the mission of the NIDCD.

Public health relevance
No changes from originally awarded application. PROJECT NARRATIVE There is a critical need for interdisciplinary research in the area of human communication and its disorders. The Boys Town National Research Hospital postdoctoral training program is designed to provide trainees with the expertise required to develop successful independent research programs through training in a large center comprising a highly collaborative and unique mix of behavioral and clinical translational research programs.